Endolysins as tools to eradicate pneumococcal biofilms and development ofprotective immunity

Project Summary
Streptococcus pneumoniae (Spn, the pneumococcus) are Gram-positive bacteria and the leading cause of
community-acquired pneumonia worldwide. The World Health Organization estimates >1.6 million deaths are
the result of Spn infection each year, with children and the elderly being the most susceptible populations. Major
problems of pneumococcal disease include the acquisition of antimicrobial resistance and the global spread of
resistant clones. In addition, these problems are magnified by the major disadvantages of the current capsular
polysaccharide-based vaccines, such as serotype specificity and the resulting incomplete coverage. An
emerging way to address the growing antimicrobial resistance problem is the use of bacteriophage endolysins.
These enzymes are capable of degrading the bacterial peptidoglycan, killing and dispersing biofilm bacteria and
its matrix. In preliminary studies, we have developed a chimeric derivative of the well characterized Cpl-1
endolysin that displays >100-fold increase in antimicrobial activity, termed ClyX-1. We also show the ability of
this new endolysin to lyse planktonic Spn, and importantly we also observed that ClyX-1 was able to kill biofilm
Spn, as well as disperse the biofilm matrix. In addition, we have shown that upon Spn nasopharyngeal
colonization, activation of programmed necrosis, i.e. necroptosis, leads to development of antigen-specific
antibodies. Of note, treatment of colonized mice with ClyX-1 further promoted necroptosis activation, suggesting
endolysin treatment may enhance development of protective immunity against Spn. Herein, we aim to address
three overall hypotheses: a) that endolysins are efficient pneumococcal anti-biofilm agents, b) that endolysins
can be an effective way to prevent Spn colonization in a serotype-independent manner, and c) that intranasal
treatment with endolysins promotes protective immunity, to prevent re-colonization and severe disease. We will
use a combination of in vitro and in vivo studies with static and dynamic biofilms, mice, biochemistry (characterize
and benchmark pneumococcal endolysins), transgenic mice (to define the role of programmed cell death in
protective immunity), molecular and immunological techniques and next generation technologies (proteomics,
single cell transcriptomics) to establish better understanding of the effects of endolysin treatments against
pneumococcal disease in vivo and test their effectiveness in development of long-term serotype-independent
protective immunity.

Public health relevance
Project Narrative Streptococcus pneumoniae is a leading cause of community-acquired pneumonia and infectious death worldwide. Current vaccines are mainly based on the capsular polysaccharides and are limited in the range of coverage, emerging non-vaccine serotypes and antimicrobial resistance. The proposed study will define the effectiveness of a novel endolysin as a point of care therapeutic and its use as a mucosal vaccine proxy for development of serotype-independent protective immunity.